Core B Cellular Core

Core B Project Summary:
The Goal of the Cellular Core (Core B) is to provide innovation and support to this Program Project to investigate
HIV-1 Env antagonism in the context of the conformational states sampled by native HIV-1 Env. Core B will
evaluate the impact of the small-molecule antagonists on sensitizing HIV-1-infected cells to antibody-dependent
cellular cytotoxicity (ADCC). Core B will also help delineate the mechanisms of action of small-molecule Env
inhibitors on trimeric Env expressed at the cell surface. Specifically, Core B will: (a) evaluate the ability of small-
molecule Env entry inhibitors for their ability to sensitize HIV-1-infected cells to ADCC and (b) assess their impact
on the conformation of functional Env trimers expressed on cell surfaces. Despite not being officially part of the
Program Project in the most recent grant period, the Finzi laboratory has been a long-term collaborator and
successfully interacted with Virology (Sodroski), Cyclic Peptides and Peptidomimetics (Chaiken), Small Molecule
Synthesis (Smith), and Single Molecule FRET (Mothes) Projects to advance the understanding of Env
conformational changes at the surface of infected cells, understand how Env conformations are modulated by
different small-molecule antagonists generated by the Program Project and assess their impact on Env
recognition and ADCC responses mediated by anti-Env antibodies and HIV+ sera.